Molecular Aspects of Cytomegalovirus Latency

Program Director/Principal Investigator (Last, First, Middle): Nelson, Jay A.
RELEVANCE (See instructions):
The overall goal of this project is to elucidate cellular signaling pathways regulated by HCMV miRNAs that
determine viral latency or reactivation.